Molecular mechanisms of gap junction promotion of lesion formation in Endometriosis

Invasive cell behavior is a component of normal (blastocyst implantation, extravasation) and pathogenic
processes (metastasis, endometriosis), and is initiated by heterotypic contacts between cells. There is strong
evidence, particularly in metastatic cancer, that gap junction (GJ) mediated intercellular coupling (GJIC) between
the invading cells and target tissue plays a critical role. Yet gap junctions have not been studied in the most
common invasive pathogenesis  endometriosis. Endometriosis is thought to arise through retrograde
menstruation of endometrial tissue to the peritoneum (occurring in most women), but there is active debate as
to whether the disease is due to changes in the endometrium (the seed) or a permissive peritoneal environment
(the soil). Project 1 demonstrated a striking downregulation of GJ genes in stromal cells (ESCs), and an inverse
upregulation in epithelial cells (EECs) that follows the progression of the disease, and could serve as a diagnostic.
Here we show that ESCs from endometriosis patients are unique in showing a large induction of GJIC upon
interaction with peritoneal mesothelial cells (PMCs). This heterotypic GJIC was critical for the ESC invasiveness
by inducing a disruption of the barrier function of the mesothelium. Conversely, PMCs also selectively affect
ESCs from endometriosis patients by triggering Cx43 assembly into GJs, and by inducing a Mesenchymal to
Epithelial Transition (MET). These results lend strong support the seed hypothesis.
The current proposal builds on these results within the collaborative environment of a P01 that will allow a
comprehensive analysis of how intercellular interactions in endometriosis lead to lesion formation. This will
include understanding: (a) How GJ, and related adhesive genes, are regulated in endometriosis (Project 1); (b)
how ESCs and PMCs initially recognize and stably adhere to one another (Project 3), leading to GJ formation,
and; (c) how these GJs induce both modification of the PMC barrier function and promote ESC invasive behavior
(Project 2). The goals of Project 2 will be achieved through three aims:
Aim 1: Establish what functions of Cx43 are important for initiating invasiveness (i.e. GJIC, hemichannels,
protein scaffolds) (1.1) and identify the molecular changes induced in PMCs that disrupt barrier function (1.2).
Aim 2: Explore the converse effects of PMCs on endometriosis-derived ESCs by assessing if HA-CD44
interactions (Proj. 3), or other signals, induce heterotypic GJ formation (2.1), exploring the dependence of
molecular changes induced in ESCs by PMCs (e.g. MET) on heterotypic GJIC (2.2), and whether PMCs derived
from the peritoneum of control or endometriosis patients (the soil) differ in the effects they elicit (2.3).
Aim 3: Validate the in vitro models for relevance to endometriotic lesion formation in a syngeneic mouse
transplant model, exploring the roles of Cx43 in both endometrium (3.1) and peritoneal mesothelium (3.2).
Results from Aims 1 and 2 will be guided by, and help inform, the genetic screens in Project 1, and cells isolated
from lesions isolated in Aim 3 will be analyzed in Project 1, providing a direct comparison to patient samples.
Project Summary/Abstract